Policy as a Structural Barrier and Facilitator of Latinx Youth Mental Health

PROJECT SUMMARY/ABSTRACT
Latinx adolescents experience higher rates of behavioral health risks compared to their non-Latinx Black and
White peers, particularly for marijuana, alcohol, and cocaine use, depression, and suicidality. Poor mental
health and substance use have been attributed to experiences of adversity, stress, and perceived interpersonal
discrimination. Advances in the field of Latinx youth mental health research has been largely focused on
individual and interpersonal determinants. Few studies examine the impact of social and environmental
contexts, such as those related to immigration status, on Latinx youth mental health. Laws and policies at
federal, state, and local levels, or the absence of such laws, also affect Latinx immigrant stress and access to
resources, increasing mental health risk for Latinx adolescents. These policies shape anti-immigrant
environments and prejudice toward Latinx youth, amplifying experiences of stress and mental health issues.
Inclusive immigration policies increase access to health and social resources. Research examining pathways
between state and local and the mental health of Latinx youth is needed. The proposed study will fill gaps by
applying a transdisciplinary approach to understand and intervene a health disparity and equity issue. The
objectives of this research are to: (1) construct a state-level dataset on interrelated policies that structure
access for Latinx youth; (2) use quasi-experimental methods to quantitatively estimate the effects of state-level
policies on Latinx youth mental health and qualitatively explore how policies shape the social lives of Latinx
youth; and (3) develop community-informed recommendations for prevention and intervention solutions. With a
focus on interdisciplinary collaboration, Temple University offers early career scholars the intellectual and
practical resources to develop into successful independent investigators. The overarching training plan for this
K01 application serves to consider the effects of macrolevel policies that either promote health or produce
inequities related to mental health. The training plan is designed to develop the candidate’s skills in public
health law research and legal epidemiology, quasi-experimental design methods and community-engaged
research to develop ground-level recommendations for prevention and intervention. By engaging in
coursework, trainings, applied experiences, and national conferences, complemented by a transdisciplinary
team of mentors from law, public health, health behavior and translational research fields, Dr. Villamil Grest’s
training and career development plan provides an opportunity to advance her interdisciplinary skills to
understand the upstream, structural level factors that affect the health and well-being of Latinx youth. To
achieve success as an independent scholar and researcher, this K01 will provide skills for the PI to become a
multimethod investigator, examining the social and structural factors that contribute to Latinx youth mental
health disparities, and to inform community-engaged prevention programs and policies.

Public health relevance
PROJECT NARRATIVE Latinx adolescents are disproportionately at risk for poor depression and suicidality and are exposed to adversity, stress, and discrimination experiences. There remains a need for research understanding the effect of laws and policies on Latinx youth mental health to broaden the scope of prevention and intervention focused on upstream factors. The proposed study fills this gap by using rigorous methodology to examine the influence of macrolevel policies on Latinx youth mental health and to inform effective community-engaged strategies.